Human and Mammalian Genetics and Genomics: the McKusick Short Course

PROJECT SUMMARY/ABSTRACT
Human and Mammalian Genetics and Genomics: the McKusick Short Course, developed through a six- decade
long partnership between Johns Hopkins University and The Jackson Laboratory (JAX), trains the next
generation of basic research and medical genetics professionals. The McKusick Short Course is purposefully an
intense, two-week program that covers human and mouse genetic and genomics processes and the
mechanisms of human disease. With graduate students, postdoctoral fellows, medical genetics residents, and
faculty being the dominant audience, the course offers ~50 lectures, 10 workshops, multiple evening lectures by
featured speakers, a poster session, and both formal and informal networking opportunities over a 12-day period,
uniquely providing medical genetics, mouse genetics, and ethical, legal, and social implications of genomics
content training. The content delivered by the Short Course would normally be covered by one or many more
graduate-level, semester-long university courses. Additionally, the McKusick Short Course will be delivered in a
hybrid format, with online/virtual access to the seminars and, where practical and feasible, the workshops. The
hybrid format enhances inclusivity by reducing barriers to participation for individuals who could not
otherwise attend. Course participation by historically underrepresented groups (URGs) in science increased
nearly 50% during the prior funding period, and well outstrips current estimates of URG enrollment in graduate
school and post-doctoral and faculty employment in the US. JAX continues to be deeply committed to recruiting
and training a diverse group of biomedical scientists, with scholarships to be provided to enable in-person
attendance. Diversity will also be discussed with regards to the initiatives, tools, and resources being generated
to study the genetic basis of disease. This includes best practices for genetics and genomics research to address
ongoing health care disparities, the need for studies of genetically diverse models and populations, and
representation of diverse backgrounds within genetic databases and samples.

Public health relevance
PROJECT NARRATIVE Most human diseases are complex, resulting from interactions between genetic loci. Human and Mammalian Genetics and Genomics: the McKusick Short Course will train a cadre of highly skilled, diverse young scientists on the genetics and genomics of human disease. With a combined focus on medical genetics, mouse genetics and model systems the course will forge a link between basic and clinical research enabling ongoing dialogue and thereby fostering productive clinical outcomes.